Data-informed Stepped Care (DiSC) to Improve Adolescent HIV Outcomes

ABSTRACT
This administrative supplement requests funds to provide viral load assays for DiSC participants to optimize
utility of stepped tool and to retain cluster a RCT design that includes viral suppression as an outcome. Our data-
informed stepped care (DiSC) intervention assigns adolescents and young adults (AYA) in HIV care in Kenya to
different intensities of health services according to their need. To assign AYA to specific services, health care
workers use a risk assessment tool to identify AYA needing intensified care. They also identify AYA thriving in
HIV care needing less intensive services to enable programs to appropriately allocate limited resources.
Unfortunately, viral load supplies have been limited in Kenya resulting in absence of viral load assays for over a
year for many AYA HIV care clients. We request budgetary support to cover viral load assays for participating
AYA at two points: at enrollment into the trial to inform step allocation and at exit for secondary outcome of viral
suppression. This will provide important insights on the effectiveness of the intervention and mechanisms of
effectiveness and will add important value to the DiSC RCT. Scientific aims are unchanged.

Public health relevance
PROJECT NARRATIVE Our data-informed stepped care (DiSC) intervention matches adolescents and young adults (AYA) in HIV care in Kenya to different intensities of health services according to need. Viral load supplies have been limited in Kenya resulting in an absence of routine testing for AYA HIV clients in routine care over the last year. Purchasing these tests for study participants will inform which services adolescents need and will allow assessment of trial effectiveness.